Diversity Supplement to Skeletal Myosin-Binding Protein C Regulation and Structural Dynamics

Title of project: DIVERSITY SUPPLEMENT TO SKELETAL MYOSIN-BINDING PROTEIN C REGULATION &
STRUCTURAL DYNAMICS.
Summary of the diversity supplement to the parent project.
Skeletal myosin-binding protein C (MyBP-C) plays a major role in the modulation of cardiac function by its
phosphorylation and causes deficits in contractile function due to MyBP-C mutations in distal arthrogryposis (DA)
and the role of phosphorylation and DA mutations is not known. Our goal is to understand the molecular
biophysics of muscle and to train the next generation of muscle biophysicists, inclusive of diverse trainees. The
parent research project and diversity supplement ask fundamental questions about the role of protein interactions
and structural dynamics that regulate function in skeletal muscle. To gain insight into the correlation of structure-
function involved in MyBP-C mechanisms in physiological and pathological settings, we will probe the actin-
myosin-MyBP-C complex of these proteins in solution with varied binding, phosphorylation, DA mutations, and
MyBP-C drugs. Our core technology is site-directed spectroscopy, applied to purified MyBP-C and actin/myosin
filaments. We will apply innovative complementary methods in site-directed labeling and spectroscopy to
correlate protein binding, structural dynamics and function. We will test the central hypothesis that
phosphorylation and DA mutations influence N-terminal and central domain skeletal MyBP-C binding with actin
and/or myosin in a dynamic equilibrium to modulate contraction. Related to the parent grant, the first period of
the diversity supplement focuses on using spectroscopic approaches to accurately measure the structural
dynamics within, and adjacent to, the Pro/Ala-rich linker (P/A) of purified skeletal MyBP-C fragment C1-C7,
primarily by measuring nanometer distances and molecular disorder. Major emphasis is placed on detection of
conformational changes (structure) within and nearby MyBP-C’s P/A due to phosphorylation, DA mutation, actin
or myosin binding (function), and drugs. By including the location of probes in P/A and in adjacent C1 and C2
domains, the Candidate will measure structural changes. Fluorescently-labeled MyBP-C will be prepared to
acquire fluorescence lifetime using time-resolved methods. Human splice variants containing and missing the
phosphorylation site in long and short forms in P/A will be evaluated. In the second period, the Candidate will
learn new skills in spectroscopic data fitting analysis to determine probe-to-probe distances and disorder in N-
terminal and central domain MyBP-C. The third period will provide molecular details of the structural dynamics
upon phosphorylation of P/A in long form sMyBP-C and actin- or myosin- MyBP-C complexes. The Candidate
will systematically build in model system complexity, from unbound to actin/myosin-bound MyBP-C, upon
phosphorylation. Spectroscopic study of sMyBP-C regulation will determine protein interactions and structural
dynamics, providing key insights at the myofilament level to be applied for understanding fundamental
mechanisms in the muscle cell. This project is grounded in fundamental biophysics mechanisms, but MyBP-C
has emerged as a therapeutic target for skeletal muscle disease. Thus, of our work lays a foundation for testing
identified drugs and development of screens for drug therapies using our unique spectroscopic approaches.

Public health relevance
PROJECT NARRATIVE We aim to determine the molecular requirements for healthy skeletal muscle function, in order to pave the way for discovery and design of more effective therapies for muscle disease and weakness. Our work will answer crucial questions about how the protein myosin-binding protein C (MyBP-C), a cause of distal arthrogryposis, functions in skeletal muscle, using reporter probes to visualize dynamic protein structures in domains C1-C7 in MyBP-C. This research will greatly improve the human health prospects for understanding disease by determining effects of disease mutations and MyBP-C drugs, and developing tools that can be used to discover novel treatments while providing training and career development for the next generation of diverse scientists.